Postdoctoral Research Training in Lung Injury and Inflammation

Project Summary/Abstract
We enthusiastically submit this application for a new T32 training program here at the University of Illinois
Chicago (UIC) entitled Postdoctoral Research Training in Lung Injury and Inflammation. This new
program builds upon our experience and success achieved over a 15-year period with two prior and
completed postdoctoral T32s based here in our Division of Pulmonary, Critical Care, Sleep, and Allergy.
The primary goal of our T32 training environment is the career development of the next generation of
scientific leaders in the fields of pulmonary and critical care medicine in a multi-faceted research and
training environment focused on the overall pathophysiologic theme of Lung Injury and Inflammation.
Comprehensive training using state-of-the-art approaches will be provided along three integrated and
complementary thematic pathways: 1) Molecular Mechanisms and Preclinical Models, 2) Computational
and Omic Approaches, and 3) Comparative Effectiveness and Health Inequality. These tracks constitute
the corner stones of medical research today: (i) elucidating basic molecular-cellular mechanisms of the
lung disease; (ii) utilizing advanced “big data” approaches to generate novel insights into disease; (iii)
evaluation of the effectiveness of interventions and assess for possible inequality. This innovative training
program utilizes state-of-the-art research approaches to produce a vibrant and productive training
environment. Our underlying premise and unifying hypothesis is that an integrated program
focused on cutting-edge research approaches will inspire a new generation of successful
scientific leaders in lung diseases. With frequent input and feedback from faculty, trainees, and internal
and external advisors, we continually enhance and improve our training environment to optimize the
career development and scientific success of our trainees. Programmatic highlights include the following:
a) training opportunities led by faculty experts in acute lung injury, pulmonary hypertension, lung cancer,
precision medicine, computational modeling, healthcare design, implementation science, etc.; b)
Research Advisory Committees for each trainee that are actively engaged and provide individualized
training plans that specify timelines and target milestones; c) recent T32 graduates and current “K-level”
junior faculty actively participate as positive role models and assigned “near peer” advisors for every
trainee; d) instruction in responsible conduct of research, reproducibility and rigor, bias reduction, and
grant writing; e) frequent “360 degree” evaluations of the program with emphasis on current and former
trainee reviews and input. Postdoctoral candidates will be accepted for 2-3 years of research training
based upon a comprehensive holistic review. Four trainee positions will be available each year.

Public health relevance
Project Narrative The primary goal of our T32 training program is the career development of the next generation of scientific leaders in the fields of pulmonary and critical care medicine along three integrated thematic pathways that provide comprehensive training in translational research focused on the pathophysiologic processes of lung injury and inflammation. Our strong mentorship platform derives from a large group of senior investigators who are leaders in multidisciplinary research and emphasize novel investigative approaches in an ethical and scientifically responsible environment. We are committed to training the next generation of scientific leaders in pulmonary research, including individuals from under-represented groups.